Cardiac Imaging of Thoracic Fat and Aortic Stiffness in Older High Risk Patients

DESCRIPTION (provided by applicant): The candidate is an Instructor in the Section on Gerontology and Geriatric Medicine in the Department of Internal Medicine. Her previous research focused on the effects of exercise training on changes in cardiovascular disease risk factors in older persons. Receipt of this K01 award will provide training in imaging, epidemiology, and vascular biology/mechanics, thereby equipping her with the skills necessary to become an independent researcher in the field of cardiovascular aging. Research: The proposed research will be an ancillary study to the Vascular Stiffness and Pulmonary Edema Study, a prospective study examining the association between dobutamine stress-induced changes in aortic stiffness and flash pulmonary edema warranting hospital admission in older high risk patients. The major aims of the present study are to 1) quantify the relationship between pericardial and perivascular adipose tissue (PCAT, PVAT) and dynamic changes in aortic stiffness in response to dobutamine-induced stress and 2) determine whether PCAT and PVAT predict cardiac events over a mean follow-up of 3.5 years. Potential mechanisms underlying the association between PCAT and PVAT and the outcomes will also be examined, including the possibility of a local effect that is perhaps mediated by adipocyte-derived factors (i.e. adipokines). Of particular interest is adiponectin, which is expressed in both PCAT and PVAT and has potent effects on cardiovascular function and insulin action. The hypotheses are that PCAT and PVAT will be positively associated with dynamic changes in aortic stiffness and that higher levels will be associated with an increased risk of future cardiac events. We also anticipate that these relationships will be independent of traditional risk factors, as well as abdominal visceral fat, adiponectin, and insulin resistance. This K01 award will provide the candidate with protected research time and mentored training to learn the technical and statistical methods to test these specific aims. The knowledge she acquires during the conduct of this study will ultimately provide her with expertise in the application of MRI to the assessment of interventions designed to alter the trajectory of age- related changes in vascular function and cardiovascular disease risk. Environment: There is an enriched research and training environment in aging-related studies within the WFU School of Medicine. The successful completion of the candidate's research and career goals will be guided by a highly-qualified, multidisciplinary team of mentors and consultants with expertise in epidemiology (Drs. Kritchevsky and Ding), cardiac imaging (Dr. Hundley), regional body fat distribution (Drs. Nicklas and Ding), cardiovascular aging (Dr. Kitzman), and biostatistics (Dr. Leng).

Public health relevance
PUBLIC HEALTH RELEVANCE: This study will help to refine the relationship between obesity and cardiovascular disease risk by determining the importance of fat around the heart and blood vessels in relation to aortic stiffness and risk of future cardiac events. This knowledge will be useful in developing randomized controlled trials of interventions that may reduce the morbidity, mortality, and health care costs associated with cardiovascular diseases. PROJECT NARRATIVE This study will help to refine the relationship between obesity and cardiovascular disease risk by determining the importance of fat around the heart and blood vessels in relation to aortic stiffness and risk of future cardiac events. This knowledge will be useful in developing randomized controlled trials of interventions that may reduce the morbidity, mortality, and health care costs associated with cardiovasculr diseases. __SpecificAimsTextDelimiter__ 10. Specific Aims Arterial stiffness, a robust manifestation of vascular aging,7 is associated with increased risk for cardiovascular disease (CVD) and its sequelae, including heart failure, stroke, atherosclerosis, myocardial infarction, and mortality.7-17 The mechanistic basis for age-related arterial stiffness is not well understood; however, the presence of CVD risk factors, such as obesity and insulin resistance, may accelerate vascular changes that result in arterial stiffening.18 While arterial stiffness is associated with both total and abdominal obesity,19-27 these measures may not be adequate to characterize the role of localized fat depots in close proximity to vascular conduits, emphasizing the need for better characterization of regional fat depots. In this regard, the novel and direct assessment of fat around the heart (i.e. pericardial adipose tissue, PCAT) and aorta (i.e. perivascular adipose tissue, PVAT) may provide more anatomically relevant and clinically significant risk factors for arterial stiffness and CVD. We have preliminary data supporting a positive association between PCAT and arterial stiffness in a large multi-ethnic population, but this relationship needs to be studied in other cohorts. Also, potential mechanisms underlying the association between PCAT/PVAT and arterial stiffness need to be examined, including the possibility of a local effect that is perhaps mediated by adipocyte-derived factors (i.e. adipokines) that influence cardiovascular function and insulin action. Of particular interest is adiponectin an adipokine that is expressed in both PCAT and PVAT, where it has been shown to regulate coronary blood flow and vasodilation, respectively.28-31 In addition, adiponectin increases glucose uptake and improves insulin sensitivity.32,33 Although we will not be able to measure the local expression of adiponectin, we will measure systemic levels which will allow us to determine whether the association of PCAT/PVAT with aortic stiffness is independent of this biomarker. We propose to examine the cross-sectional association between PCAT/PVAT and dynamic changes in aortic stiffness, and the longitudinal association between these fat depots and cardiac events in 450 participants enrolled in the Vascular Stiffness and Pulmonary Congestion (PREDICT) Study. The main objective of PREDICT is to determine if dobutamine stress-induced changes in aortic stiffness independently predict the future occurrence of flash pulmonary edema warranting hospitalization in an older population (55-85 yrs) at high cardiovascular risk (defined as having hypertension, diabetes, or coronary artery disease). While mild increases in aortic stiffness normally occur with dobutamine, large increases are indicative of impaired cardiovascular function. PREDICT is the first large epidemiologic study using innovative MRI-based measures of cardiac and vascular function under rest/stress conditions to assess risk of cardiac events. PREDICT also utilizes novel MRI sequences that allow for the simultaneous measurement of PCAT and PVAT. As such, the proposed ancillary study will take advantage of existing MRI scans, providing an ideal learning environment, as well as a scientifically-sound and cost-effective opportunity to determine the importance of localized fat depots in relation to aortic stiffness and risk for cardiac events. The main hypotheses to be tested are that higher PCAT and PVAT will be associated with greater stress-induced changes in aortic stiffness and an increased risk for future cardiac events in an older community-based population at high cardiovascular risk. We also anticipate that these relationships will be independent of abdominal visceral fat, adiponectin, and insulin resistance. Specific Aim 1: To determine if PCAT and PVAT are associated with dobutamine stress-induced changes in aortic stiffness, independent of traditional CVD risk factors and: 1.1. Abdominal visceral fat; 1.2. Circulating adiponectin levels; and 1.3. Insulin resistance (as assessed by the HOMA index) Specific Aim 2: To determine if PCAT and PVAT predict cardiac events over a mean follow-up of 3.5 yrs, independent of traditional CVD risk factors and: 2.1. Abdominal visceral fat; 2.2. Circulating adiponectin levels; and 2.3. Insulin resistance (as assessed by the HOMA index) This K01 award will allow me to address these aims by providing protected time for mentored research and training in MRI, CVD epidemiology, and vascular biology/mechanics. The knowledge I acquire during this period will prepare me to be an independent researcher in the field of cardiovascular aging, with expertise in the measurement of localized fat depots and aortic stiffness using MRI. The results of the proposed study will help to refine the relationship between obesity and CVD by determining the significance of fat depots around the heart and blood vessels in older individuals at high CVD risk. This information will allow me to generate new research hypotheses for further studies in this area and will be useful for developing interventions aimed at preventing obesity-related CVD morbidity and mortality.